RFA-DP-24-031: Longitudinal Follow-up of a Nationwide Multiethnic Cohort of Veterans and Non-Veterans with Interstitial Cystitis

ABSTRACT
Interstitial cystitis/bladder pain syndrome (IC) is characterized by pain related to the bladder, usually
with frequency and urgency, in the absence of other diseases that could cause these symptoms.
Given the difficulty in diagnosing IC, the US prevalence of IC was unknown until recently.
With funding from the Centers for Disease Control and Prevention (CDC), we p r e v i o u s l y
determined the national prevalence of IC by creating a nationwide cohort of IC patients using the
largest integrated health system in the US: The Veterans Affairs (VA) Health system. After a detailed
chart review of nearly 3,000 subjects, adjusting our findings based upon age and gender strata to the
US general population, we found the national prevalence of IC to be 1.08% in women and 0.66% in
men. However, key unanswered questions remain: What is the natural history of IC? Can we predict
a diagnosis of IC with a urinary biomarker? What are typical IC treatment patterns? Is there variation
in care and do these patterns of care affect IC progression and remission? What is the relationship
between IC and other comorbidities such as depression and post-traumatic stress disorder? Do
health disparities in IC outcomes exist by race/ethnicity, gender, geography (urban/rural), and
socioeconomic status?
Funded by our current CDC award, we aimed to address these questions by creating a
prospective cohort of 378 subjects who have IC by ICD-9 codes, further confirmed by chart review,
and followed subjects annually via validated questionnaires. By following our nationwide cohort of IC
subjects and two additional clinical cohorts, we hypothesize we can gain greater understanding of IC
treatment patterns, clinical outcomes, and the impact on quality of life (QoL).
We propose to expand our prospective cohort of 378 VA patients to 500, adding additional
cohorts at UCSD (200 patients) and Kansas University (100 patients). Patients will be contacted
yearly to complete validated QoL surveys, 24-hr food recalls, and Fitbit activity trackers. We will also
capture additional symptom flares and follow the cohort for the development or worsening of
comorbid conditions (PTSD and depression). We will measure disparities in care and outcomes,
and lastly, we will validate a set of previously tested urine biomarkers.
Finally, we propose to continue the very productive partnership we’ve established with the IC
Network (ICN). The ICN will continue to educate the larger IC community and provide a forum for
disseminating our research findings. This study will make major strides in our understanding of IC and
ultimately improve QoL for IC patients.

Public health relevance
PROJECT NARRATIVE We propose to follow and expand our previously created cohorts of veterans and non-veterans with IC to understand treatment patterns, clinical characteristics, and lifestyle factors. We will also validate previously identified urinary biomarkers for IC. Finally, we will work with the IC Network (ICN) to continue educating the larger IC community as well as providing a forum for disseminating our research.